Tracking and Evaluation Core

Tracking & Evaluation Core Project Summary
The Tracking and Evaluation (T&E) Core works closely with the Administrative, other Cores and Pilot
Project Program to analyze the performance of the Great Plains (GP) IDeA-CTR in a collaborative
evaluation model. The evaluation addresses 3 specific aims: Aim 1) Assess the effectiveness of the GP
IDeA-CTR in creating the environment and culture to support innovative and collaborative clinical and
translational research; Aim 2) Evaluate how GP IDeA-CTR programs, resources, and services affect scientific
productivity and the movement of research across the translational spectrum, with a focus on short- and long-
term goals, milestone attainment, budget effectiveness, and leveraging data for informed decisions, strategic
planning, and continuous improvement; and Aim 3) Use T&E feedback across teams and the network to
improve collaborative team science, in a model that provides stakeholders with actionable metrics to assess
GP IDeA-CTR outcomes, impact, and benefits to the community and region. The evaluation process uses
cutting-edge, validated approaches and 14 evaluation metrics that include several tools with established
validity evidence. The collaborative approach will engage CTR leadership and governance, Cores, and other
stakeholders in ensuring the usefulness of evaluation and feedback, while balancing the value of information to
stakeholders against the burden of data collection. Evaluation is expected to have a positive effect on GP
IDeA-CTR priorities, such as enhancing the environment for team science, moving translational research
across the spectrum, and fostering team science competencies. This will enhance the ability of the GP IDeA-
CTR to maximally benefit stakeholders and the region, identify factors associated with successful CTR
outcomes, and add to the repository of methods and tools for evaluating change and improvement efforts in
large, complex translational science systems.